NF2-Associated Meningiomas: From Omics Discovery to Targeted Therapy

Neurofibromatosis 2 (NF2) is characterized by vestibular schwannomas, and meningiomas that show loss of
the NF2 tumor suppressor gene. Meningiomas arise from meningothelial arachnoid cap cells and are the most
common primary intracranial tumors in adults. NF2 inactivation is frequently associated with sporadic
meningiomas, particularly in primary atypical (WHO grade II) tumors. Meningiomas that progress despite
surgery and radiation are responsible for significant morbidity and mortality. Therefore, effective systemic
therapies are greatly needed. For meningioma modeling and preclinical drug screening, we employ human
primary meningioma (MN) cell lines derived from surgically resected tumors and CRISPR-Cas9 genome-edited
isogenic, human arachnoidal cell lines (ACs) that either express or lack NF2. Employing these models, we
established that NF2-deficient meningiomas reveal aberrant activation of mTORC1/mTORC2 signaling, which
led to clinical trials for NF2 and meningiomas. Recently, we undertook large-scale kinome, transcriptome and
drug screening studies in our AC and MN cell models to identify other potential targets. Kinome and
transcriptome data revealed increased activation and expression of several EPH receptor family tyrosine
kinases (EPH-RTKs), Src family kinase members (SFKs) and c-KIT, which are all targets of dasatinib, which is
recently published. Our ‘omics approach also identified other interesting candidates, including ligands NRG1,
HBEGF and apelin, and AMPK-related kinases, particularly NUAK2, to be consistently upregulated in the
kinome and transcriptome of NF2-null AC/MN cells. Our recent results suggest that NRG1 expression and
ERBB3 signaling is regulated by mTORC1 signaling. We plan to examine whether NRG1 alone or factors such
as HBEGF and APLN are also regulated by mTOR or play a role in downstream signaling in NF2-null MN cells.
We propose to understand the mechanism and biological significance of elevated expression and activation of
NUAK2 in meningioma. Further, our large-scale drug screening efforts, in collaboration with NIH-NCATS,
revealed a set of proteasome pathway related drugs exhibiting cytotoxic effects in NF2-null cells. Here we
propose to examine three different drugs targeting the proteasome (provided by Millennium-Takeda
Pharmaceuticals), alone and combined with TAK-228 (mTOR inhibitor) in 5 grade I, 5 grade II and 5 grade III
MN lines with NF2 loss. More importantly, we propose to undertake single cell RNAseq along with array CGH
in NF2-deficient meningiomas and their corresponding primary cell lines to define tumor heterogeneity and
correlate with drug response. Anti-tumor efficacy of proteasome drugs will also be evaluated in orthotopic NF2-
deficient benign and malignant meningioma models. Our overall approach of (i) leveraging the ‘omics and drug
screening results, (ii) characterizing tumor heterogeneity and correlating with drug response, and (iii) testing
potential drugs in orthotopic NF2-deficient in vivo models is timely, novel and will provide a framework to
pursue new avenues in NF2 and meningioma research for clinical care.

Public health relevance
Project Narrative Our earlier work establishing aberrant regulation of mTORC1 and mTORC2 signaling in NF2 led to clinical trials with mTORC1 inhibitor everolimus for NF2, and dual mTORC1/mTORC2 inhibitor, AZD2014, for NF2- associated and sporadic meningiomas. Our ongoing studies uncover role of growth factors and other receptor tyrosine kinases in NF2-negative tumors, and potential cross talk between mTOR and other signaling pathways. This project will explore these druggable therapeutic targets along with other promising drugs in clinical development using cellular and animal models of NF2-deficient meningioma, which will have a direct impact on developing novel therapeutic strategies and promoting public health.